Upper Midwest Agricultural Safety and Health Center

Summary
The UMASH Center continues to develop productive multidisciplinary collaborations. Our work implements a
One Health approach. Evidence of this is through our communications, collaborations, and cooperation of the
varying human, animal, and environmental systems that are integral to health and safety. Our innovative
research projects build on past success and address important and timely health and safety problems relevant
to the agricultural workforce in the Upper Midwest, the country, and the world. The outreach and engagement
activities are active, relevant, and forward-looking, with widely accessed and available resources. Our
Emerging issues program addresses timely topics relevant to today's issues encompassing input from our
human, animal, and environmental experts and stakeholders. We recognize the ever-changing agricultural
landscape and our need to be nimble to address those needs. Our robust evaluation program and personnel
will ensure our work will be impactful. The UMASH team looks forward to continuing to address issues related
to the health and well-being of agricultural workers and their families.

Public health relevance
Agriculture work can be hazardous. As agriculture evolves to meet increasing global food demand, the occupational health risks encountered by the agricultural workforce will evolve with some hazards being eliminated and others emerging. Understanding these changes is essential to protecting the health of agriculture workers and their families.